Loneliness in Aging with Schizophrenia: Effects of Real-time Positive and Negative Social Motivation

PROJECT SUMMARY/ABSTRACT:
Chronic loneliness is a pervasive issue in persons with schizophrenia and can lead to downstream
consequences of worsening symptoms (e.g., paranoia, cognitive and functional impairments), social
withdrawal, and diminished quality of life. Central to these challenges are deficits in social motivation,
encompassing both positive motivation (i.e., desire for connection) and negative motivation (i.e., avoidance
due to anxiety). High rates of anxiety and depressive symptoms further exacerbate these motivation deficits,
hindering social engagement and intensifying chronic loneliness. Despite the critical role of social motivation in
shaping social interactions and mental health outcomes, existing research has primarily relied on static,
retrospective assessments, which fail to capture the real-time fluctuations and bidirectional relationships
between social motivation, mood, social interactions, and loneliness. The proposed F31 project will use
ecological momentary assessment (EMA) to examine these dynamic processes as they unfold in daily life. By
leveraging data from an NIMH-funded R01 study on loneliness and aging in schizophrenia, this study will
evaluate moment-to-moment fluctuations in positive and negative social motivation, and their associations with
mood, loneliness, and social interactions. Advanced statistical techniques, including linear mixed effects
models and mediation analyses, will identify mechanisms linking social motivation to loneliness and mood over
time. These insights aim to advance understanding of how momentary changes in social motivation shape
real-world experiences in schizophrenia, with the goal of identifying modifiable targets for intervention. Through
the training opportunities afforded by the F31 fellowship, the candidate will gain expertise in EMA
methodologies, advanced statistical modeling, and translational research approaches. These skills will support
the candidate’s long-term goals of becoming an independent investigator specializing in the social and
psychological mechanisms of serious mental illness (SMI) and the development of technology-based
interventions. The proposal aligns with the NIMH Strategic Plans by advancing the understanding of dynamic,
modifiable processes underlying social motivation deficits in schizophrenia, and informing innovative, targeted
intervention strategies.

Public health relevance
Project Narrative: The proposed research for this NRSA F31 will use ecological momentary assessment (EMA) to examine how real-time changes in positive and negative social motivation shape loneliness, mood, and social interactions in persons with schizophrenia. By capturing these dynamic fluctuations, this study addresses a critical gap in understanding the temporal nature of social motivation and its impact on daily functioning. The findings have the potential to inform targeted interventions enhance social functioning and emotional well-being in persons with schizophrenia, ultimately contributing to improved mental and physical health outcomes in this population.